Targeting Lysosomal Vulnerabilities in Renal Pathogenesis

Project Summary/Abstract
Autophagy is frequently upregulated in cancer cells under metabolic stress to recycle
cellular components for protein and ATP synthesis to promote cell survival. Based on its
important roles in maintaining cell viability and inducing resistance to radiation and
chemotherapy, inhibition of autophagy has become a viable therapeutic approach that has
been evaluated in clinical trials. However, there is a need to identify predictive biomarkers
to enable selection of patients that may best respond to autophagy inhibitors. Our
preliminary data demonstrates that the mTORC1 regulator REDD1 controls sensitivity to
autophagy inhibition suggesting that cancers with significant REDD1 levels, such as renal
cell carcinoma (RCC), are hypervulnerable to this therapeutic approach. Our major goal
is to investigate the mechanisms that control sensitivity to autophagy inhibition in RCC
cells to optimize its potential clinical application. In Aim 1, we will determine the role of
REDD1 as a regulator of RCC pathogenesis and sensitivity to autophagy inhibition. In Aim
2, we will investigate the mechanistic link between PIM1 inhibition and upregulation of
REDD1 with a focus on endoplasmic reticular stress. In Aim 3, we will evaluate the impact
of clinically-relevant autophagy inhibitor-based combinations for RCC therapy.

Public health relevance
Project Narrative REDD1 upregulation activates autophagy through inhibition of mTORC1. We propose to evaluate the roles that REDD1 plays in renal cell carcinoma progression, the mechanisms of PIM kinase inhibitor-mediated REDD1 induction, and the link between REDD1 expression and sensitivity to autophagy inhibition. Our overall goal is to identify novel strategies to target autophagy for renal cell carcinoma therapy.